Core A: Pathobiology Core

Project Summary/Abstract
Cancer is a highly heterogenous disease, composed of and characterized by a diverse set of genetic
phenotypes driven by complex dynamic cellular interactions within spatially distinct organized
microenvironments. The ability to accurately delineate this intra tumor heterogeneity and its contribution to
metastasis, therapeutic resistance and ultimately the impact of clinical outcomes, remains a challenge. In
addition, the molecular mechanisms underpinning the cross-talk between tumor and its microenvironment are
largely lacking.
This prostate cancer Program Project sets out to investigate the tumor cell intrinsic as well as stromal
and immune microenvironmental factors in tumor progression using single cell sequencing technologies.
Additionally, the Program will incorporate a multi-disciplinary and integratory approach that aims to integrate
single-cell RNA-sequencing and systems analyses of genetically engineered mouse and organoid models, with
complementary analyses of human tissue samples in naïve, castration-resistant and neuroendocrine tumors,
both local and metastatic.
The Pathobiology Core (Core A) will support the projects by providing expert histopathologic analysis of
murine and human tumors, validating antibodies and probes for use in mouse and human tissue, comparing and
contrasting multiple signals in epithelium and microenvironment in mouse models and patient samples.
Innovative approaches including organotypic cultures and recombination experiments will be utilized as
functional assays. Finally, refining strategies in computational methods to compare single cell analyses in human
and mouse as well as developing novel approaches to improve and automate in situ expression modalities will
represent the innovation arm of this core.

Public health relevance
Project Narrative The Pathobiology Core A will provide all Program investigators multiple pathology services. Core A is essential for the success of all projects via the expertise provided in pathological characterization of mouse and annotated human tissue. Further, Core A will provide expertise in generation and use of 3-dimensional organotypic and organoid models, performing scRNASeq experiments in highly annotated human tissue and sophisticated imaging for in situ localization of antibodies and genes discovered.